Contextual factors of the risk environment surrounding injection drug use: A real-time approach

Project Summary/Abstract
Not being changed by the proposed supplement activities.

Public health relevance
Project Narrative Not being changed by the proposed supplement activities.